CREATININE CLEARANCE DURING AMINO ACID INFUSION AND ORAL TRIMETHOPRIM

Renal reserve during amino acid infusion when tubular secretion of creatinine is blocked minimizing overestimation of glomerular filtration rate in normal controls is measured.